Intuitive, complete neural control of tablet computers for communication

Intracortical brain-computer interfaces (iBCIs) have the potential to restore motor function and
communication for individuals with severe speech and motor impairment (SSMI). While the
potential applications of iBCIs are vast, the number of people who may benefit from an iBCI has
not been quantified, nor has a methodology that quantifies an estimate of this population size
been developed.
To quantify the number of people within a major academic medical center who may benefit from
an iBCI, a postdoctoral fellow will lead the team in use of the Massachusetts General
Hospital/Brigham and Women’s Hospital (MGB) Research Patient Data Registry (RPDR). This
database consists of all MGB clinical data from 7 million patients since 1975 (3 billion
corresponding datapoints [e.g., diagnoses, procedures, etc.]). Detailed clinical records will be
reviewed to determine the likelihood of an individual benefitting from an iBCI (e.g., symptom
severity, prognosis). In our first step, we will first query the diagnosis codes for “locked-in state”
(LIS) and develop a strategy to characterize iBCI benefit of these individuals. The team will
include several clinician/neuroscientist reviewers and the study PI; inter-rater reliability will be
assessed. After completing that initial study, the postdoctoral fellow will query additional
ICD10/9 diagnosis codes relevant to communication and/or upper extremity deficits, sampling a
statistically valid subset of cases to determine the likelihood of iBCI benefit for each cohort of
patients. The postdoctoral fellow will learn from and work with a biostatistician with expertise in
neurologic disease epidemiology. The percentages of people who received care for specific
diagnoses at one academic medical center, and who would potentially benefit from an iBCI, will
then be used to extrapolate incidence and prevalence in larger populations.
Additionally, the postdoctoral fellow will evaluate the use of the investigational BrainGate neural
interface system through the development and implementation of surveys that assess system
efficacy, usability, and frequency of usage. These tools and analyses will be conducted with
current and future BrainGate study participants, and will be valuable to demonstrate how iBCI
technology may benefit future users, and to identify future desired features and applications.
Importantly, the postdoctoral fellow supported by this supplement will also promote diversity in
health-related research, bringing critical perspectives to both the performance and the content
of research to restore communication.

Public health relevance
Intracortical Brain-Computer Interfaces (iBCIs) have extraordinary potential to restore communication for people with severe speech and motor impairments, but the number of people who could benefit from iBCIs is unknown. Rather than inferring the number of iBCI candidates from disease prevalence estimates, this administrative supplement will enable a postdoctoral fellow to lead a clinical chart-review to identify more accurately the number of people with disorders of communication or mobility that could benefit from a specific, novel neurotechnology. The postdoctoral fellow will also advance the development of iBCI user questionnaires that will further inform how future iBCI users with severe, chronic impairments of communication and mobility prefer to use these restorative technologies.